Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administration Core will provide executive oversight and administrative support for all of the projects and
cores that comprise the Leukemia SPORE. The goal of the Administration Core is to monitor the activities of all
of the program components, comply with all local and federal guidelines for grant administration, and facilitate
communication and collaboration among the program members and with other Leukemia SPOREs. Accordingly,
the specific aims of the Administration Core are as follows:
Aim 1. To facilitate intra- and inter-SPORE communication and collaboration.
Aim 2. To provide administrative and fiscal oversight and support for all SPORE components.
Aim 3. To coordinate activities of the SPORE Developmental Research Program.
Aim 4. To coordinate activities of the SPORE Career Enhancement Program.
Aim 5. To assist investigators with the preparation of scholarly presentations, publications, regulatory
documents, and all other SPORE-related paperwork.
Aim 6. To encourage diversity and equity in SPORE activities.
Aim 7. To ensure that advocacy issues are addressed and included in all aspects of research involving
patients.